A Directed Evolution Approach to Affinity-Based Protein Delivery

PROJECT SUMMARY
Tissue regeneration is a dynamic, carefully coordinated process in which many proteins and cell populations
participate. Disruptions in the healing cascade caused by chronic disease or severe injury can easily impair
tissue regeneration, resulting in injuries that do not heal. Our long-term goal is to design affinity-based hydrogels
that can provide phased delivery of multiple therapeutic proteins to enhance tissue repair. We have developed
a “bottom-up” modular approach to protein delivery, in which specific affinity interactions between small protein
domains (i.e. binding partners) and therapeutic proteins are integrated into biomaterials to independently and
predictably control the release of multiple proteins. We are using directed evolution of yeast surface display
libraries to identify binding partners with high specificity and moderate affinities for proteins, to enable protein
release over different timescales. We expect that our approach will more accurately recapitulate the natural,
staggered presentation of multiple proteins during the healing cascade, providing the necessary combinations
of proteins to activate key phases of the repair process. In Aim 1, we will evolve binding partners for therapeutic
proteins using yeast surface display. We will characterize an assortment of affibodies specific to each therapeutic
protein to generate a large diversity of orthogonal, protein-affibody affinity interactions. In Aim 2, we will use
statistical modeling to optimize biomaterial properties to achieve desired protein release profiles. We will feed
this information into COMSOL bio-transport models to predict protein delivery in vitro and in vivo. In Aim 3, we
will synthesize hyaluronic acid hydrogels containing binding partners to investigate tunable co-delivery of multiple
proteins in vitro and in vivo. Our modeling results will inform the design of biomaterials that enable the delivery
of multiple proteins with distinct release profiles. In vitro protein release from hydrogels will be evaluated via
ELISA. In vivo retention of fluorescently labeled proteins within implanted hydrogels will be evaluated using
longitudinal live fluorescence imaging of rats. Ultimately, we expect to achieve independent control over the
release of a wide range of therapeutic proteins relevant to tissue repair through orthogonal protein-material
affinity interactions. We expect that our versatile biomaterial platform can be applied to the precise delivery of a
broad range of proteins and will enable systematic investigation of the timing of protein presentation required for
tissue healing. This work will lay the foundation to cultivate clinically-relevant strategies for stimulating robust
tissue repair in multiple organ systems.

Public health relevance
PROJECT NARRATIVE Coordinated protein presentation plays a critical role in tissue regeneration, but many factors can disrupt natural healing cascades, leading to poor healing outcomes. This project will employ a unique combination of directed evolution and computational and statistical models to generate a biomaterial platform that enables the precise, independently tunable delivery of multiple proteins from a single material. The ability to fine-tune the release of multiple proteins at a time will enable systematic investigation of the timing of protein delivery required for healing and has the potential to broadly enhance tissue repair in many systems.